Mentoring the next generation of researchers in pediatric autoimmunity

Abstract
Dr. Shaun Jackson, an established researcher and leader in the field of pediatric autoimmunity, seeks a K24
Mid-Career Investigator Award to expand his mentorship of junior scientists engaged in patient-oriented research
(POR) at the interface between pediatric rheumatology and autoimmune kidney disease. Dr. Jackson’s long-
term career goal is to build a translational research program dedicated towards uncovering disease mechanisms
in pediatric autoimmunity and developing novel treatments for affected children. In addition, he aims to cultivate
the next generation of basic researchers and physician-scientists dedicated to POR in pediatric inflammatory
diseases. During the period of K24 support, Dr. Jackson’s mentees will enter a structured training program that
incorporates individualized development plans (IDP), didactic coursework in the principles of POR, cutting-edge
research experiences, mentorship in writing manuscripts and grant applications, and professional networking
necessary to build a successful POR career. To support these mentorship goals, Dr. Jackson has developed a
K24 Career Development Plan for himself that focuses on: 1) training in the regulatory aspects of POR in support
of an expanded autoimmune kidney disease research program; 2) designing clinical trials of novel cell therapies
for pediatric autoimmunity; and 3) developing leadership skills in POR.
Dr. Jackson’s current and future mentees will have the opportunity to work on a diverse portfolio of funded and
proposed research studies. These include mechanistic interrogation of humoral autoimmunity in patients with
STAT1 gain-of-function syndrome (Project 1), using cutting-edge spatial transcriptomics to study kidney
inflammation human lupus nephritis (Project 2), correlative studies in patients receiving B cell-directed chimeric
antigen receptor (CAR) T cells (Project 3), and a new project centered on a rare and largely unstudied pediatric
autoimmune kidney disease, Tubulointerstitial Nephritis and Uveitis (TINU) syndrome. This research experience
and structured mentorship program will be executed within the dynamic and collaborative environment of the
Seattle Children’s Research Institute (SCRI), the University of Washington School of Medicine (UWSOM), and
the greater Seattle biomedical community, where state-of-the-art facilities and a vibrant research community
provide an ideal setting for POR training.

Public health relevance
Project Narrative Dr. Shaun Jackson, an expert in pediatric autoimmunity, is seeking a K24 Mid-career Investigator Award in Patient-Oriented Research (POR) to enhance his scientific mentorship and expand the pipeline of junior researchers studying autoimmune disorders affecting children. K24 support will enable the implementation of a structured training program for mentees while granting Dr. Jackson protected time for career development activities and mentoring junior trainees. With access to a wide range of funded and clinically-relevant research projects, Dr. Jackson's current and future mentees will receive scientific training within the collaborative and enriching environment of the Seattle Children’s Research Institute and the University of Washington School of Medicine.